Large Animal Core

PROJECT SUMMARY – LARGE ANIMAL CORE
The Large Animal Core (LAC) provides a wide spectrum of support, including efficient in vivo ocular imaging of
large animal models as well as equipment and technical support for ocular surgical procedures, to vision
scientists who are investigating fundamental processes and therapeutic strategies in large animal models. The
Core comprises an AAALAC-accredited, fully equipped microsurgical suite and three advanced imaging suites.
Ocular imaging instrumentation provided by the Core includes multiple SD-OCTs, multiple electroretinography
units, confocal biomicroscopy, digital slit lamps, tonometers, pachymeters, external digital SLR cameras, fundus
cameras, and a Pentacam imaging system. The LAC will also provide expert technical support to help
investigators understand the Core technologies and their capabilities, develop appropriate study designs,
perform procedures and/or collect data. The LAC will stimulate collaboration among vision scientists by providing
support for innovative multidisciplinary research, and it will support early-career vision scientists as they set up
their laboratories and collect data essential for future NEI grant applications.